Detecting prostate cancer aggressiveness using photoacoustic chemical imaging with photoacoustic spectral analysis

ABSTRACT
Prostate cancer (PCa), with an annually increasing incident rate, has become the most commonly diagnosed
cancer in American men. The accurate diagnosis of aggressive PCa is critical for the survival of patients.
Transrectal ultrasound (TRUS) guided biopsy, the current standard procedure for evaluating the presence and
aggressiveness of PCa, suffers from low core yield, leading to under-sampling and under-grading of clinically
significant tumors. To solve the long-standing challenges in PCa diagnosis, we propose to develop a real-time
functional imaging platform with the unique capability of quantitatively evaluating both heterogeneous gland
microarchitecture and anomalous chemical microenvironment in tumors for accurate diagnosis and prognosis of
PCa. The proposed functional imaging platform is made possible by the recent advancement in photoacoustic
(PA) imaging and biocompatible polyacrylamide hydrogel nanoscale probes (PAA NPs). Besides drastically
enhancing the sensitivity and specificity of PA imaging in detecting the tumors, the PAA NPs conjugated with
cancer-targeting ligands can be a carrier of versatile contrast agents for PA chemical imaging, offering unique
opportunities for PCa diagnosis and characterization in both preclinical and clinical settings.
The central hypothesis of this research is that the PA imaging, when powered by the functional PAA NPs, can
enable sensitive detection of PCa tumors and accurate characterization of PCa aggressiveness in vivo by
quantitatively assessing a list of imaging biomarkers reflecting prostate gland microarchitecture and cancer
microenvironment. The objective of this project is to understand the performance and limitations of the PAA NP
powered PA imaging in PCa tumor detection and characterization of cancer aggressiveness via the experiments
in clinically relevant mouse models of PCa. To examine the central hypothesis and pave the road toward future
clinical application, this research will focus on the following specific aims: Aim 1. Optimize PAA NPs for chemical
imaging of the tumor microenvironment, targeting PCa tumors, and staining prostate microarchitectures; Aim 2.
Understand the performance of PAA NP powered PA imaging in characterizing the aggressiveness of PCa via
studies in clinically relevant mouse models of PCa; and Aim 3. Develop a multivariate strategy for PCa diagnosis
and prognosis by combining the multiple cancer biomarkers from PAA NP powered PA imaging. The successful
accomplishment of this project will lead to a prototype PA imaging platform with its performance in assessing the
aggressiveness of PCa comprehensively evaluated. In the future, the proposed imaging procedure can be
seamless integrated into the framework of TRUS guided PCa biopsy to improve the core yields and decrease
the false negative rates. Moreover, the proposed PAA NP contrast agents specifically designed for PA molecular
and chemical imaging can facilitate a platform technology for understand cancer microenvironment, not only for
PCa but also for other types of solid tumors.

Public health relevance
NARRATIVE Proposed here is a novel laser and ultrasound based imaging platform which, by working together with nano- size particles carrying functional dyes, may allow not only sensitive detection of prostate cancer but also accurate differentiation between aggressive and non-aggressive tumors. In this research on clinically relevant mouse models of prostate cancer, we will test the performance of this imaging technology to pave its road toward potential clinical translation. In this future, this imaging technology could be integrated into the current standard clinic procedure, i.e. trans-rectal ultrasound guided needle biopsy, to largely enhance the accuracy in prostate cancer diagnosis.